GENE TRANSFER IN CYSTIC FIBROSIS USING E1 DELETED ADENOVIRUS

The present stud is a dose effect study designed to test for the safety and efficacy of E1-deleted recombinant adenovirus containing the CFTR cDNA under a CMV-beta actin promoter in CF nasal epithelia. Three patients will be selected for each dose. The goal is to define the safety and efficacy of the various doses as a function of time, with the ultimate goal of using these studies to understand safety, efficacy, and potential dosing intervals pertinent to this novel of therapy.